Novel Mechanisms Of MicroRNA-Mediated Anabolic Effects In Age-Related Osteoarthritis

Abstract
Osteoarthritis (OA) is the most prevalent degenerative disease in older adults with the incidence rising rapidly
after age 50 and leveling off after age 70. OA is also one of the common causes of chronic pain and the
leading cause of physical disability in older adults. Currently, there is an unmet need for therapeutic strategies
to improve the outcome for patients with OA. Our latest work identifies a list of microRNAs (miRNAs) in human
cartilage and demonstrates a strong association with a robust anabolic effect. This effect is joint-specific and
follows a distal-proximal axis gradient (high in ankle and low in hip). Studies show that a joint's identity is
maintained by synovial cells and that there is a distinct miRNA profile in different joints. Together, this suggests
that the miRNAs we identified in cartilage may originate from synovium and be involved in maintaining joint
homeostasis. In Aim 1, I will determine the synovial cell types that express these regenerative miRNAs within
human joints and the effects of age on the expression of these miRNAs. In Aim 2, I will determine the signaling
pathways responsible for the miRNA-mediated anabolic effects in cartilage and the effects of age on these
pathways. I will conduct gene set enrichment analysis to determine miRNA-mediated pathways and then use
proteomics to validate these pathways. Through this project, I will determine the miRNA-mediated mechanisms
by which synovial cells promote endogenous anabolic effects in the human joint. The key career enhancement
of this award will be the training in computational bioinformatics to analyze the complex datasets generated by
the project, and further training in aging biology to understand how aging impacts the regeneration process. To
facilitate progress toward independence, the training plan will include the coursework/workshops in
computational bioinformatics and aging biology, extensive internal and external scientific meetings, and career
professional development activities and mentorship. The research and career development plan detailed in this
proposal will be conducted with a team of outstanding mentors. Dr. Yi-Ju Li, a professor of Biostatistics &
Bioinformatics and an expert in statistics and bioinformatics, will serve as the primary mentor and focus on the
training in bioinformatics, statistics, and professional skill development. Drs. Cathleen Colón -Emeric, Virginia
Kraus (Duke), and Patrik Önnerfjord (Lund University, Sweden) will serve as co-mentors; they will facilitate
training in translational aging research, OA research, and proteomics, respectively. The environment at the
Duke University and Duke Molecular Physiology Institute, where the main research activities are located, are
ideal for the research and training activities outlined in this proposal. This award will enable me to elucidate the
novel contributions of miRNAs to joint tissue homeostasis. Advancements in this area of research have the
potential to develop as new therapeutic strategies aimed at improving the quality of life for patients with OA.

Public health relevance
Project Narrative We discovered a robust anabolic response in human cartilage that follows a distal-proximal axis gradient (high in the ankle joint and low in the hip joint); this response was modulated by the same master regulators that regulate limb regeneration in animals capable of limb regeneration. This project investigates the origins of these master regulators in synovial cells, the mechanisms involved, and how aging effects these mechanisms in human joint tissue.